MyGI Diet for Colorectal Cancer Prevention

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA
21-070. The parent grant tests methods to assist high risk individuals in attaining both the weight management
and diet quality goals for colorectal cancer (CRC) prevention. Existing recruitment plans for this study mainly
rely on clinic-based recruitment and research registries, strategies which have yielded largely well-educated,
white study populations in our prior work. Here, we propose methods to optimize recruitment and retention
using video education tools to de-mystify the research study, and personal technology assistants to address
digital literacy barriers. In the first aim, three short videos will be made for the study website to introduce study
staff, show how to reach the study site, explain the study objectives, show visit procedures and address
privacy and security concerns. The goal is to build trust and de-mystify the clinical/medical aspects of the trial.
Evaluations will include assessing the numbers of individuals contacted from the website versus other sources,
comparisons with previous recruitment efforts of high-risk individuals (numbers over time, demographics),
website feature usage, and interviews with study staff and enrolled participants to collect opinions regarding
the utility of the website. In the second aim, we will evaluate the utility of a Personal Technology Assistant to
spur both recruitment and retention of study participants. Limited technology proficiency is well documented to
reduce participation in studies that require web-based tasks. This is especially true for older individuals and
individuals with who are not yet adept at using the web. Personal Technology Assistants, who are trained to
provide digital health literacy support in a culturally sensitive manner, will assist participants with the MyGI
mobile app on request, at either the study site and/or at community sites. Evaluations will include quantitative
data such as numbers of study participants requesting this assistance as well as interviews of both study
participants and study staff. Mixed methods analysis of the quantitative and qualitative assessment data will
yield robust information on the utility of the new strategies. If effective, use of both strategies will be continued
throughout the study recruitment period. The ongoing maintenance costs will be undertaken by the parent
study since the major costs involved with implementation of these aims is in the development of the strategies.
The long-term goal of these efforts is to facilitate equitable recruitment and retention of participants in the
parent study and to provide in-depth data on the utility of the methodologies that leads to their implementation
in other trials.

Public health relevance
Project Narrative This supplement will allow the implementation and evaluation of two methods designed to spur equitable recruitment and retention of participants to a clinical trial that is aimed at improving diet in people who have risk factors for colorectal cancer. The proposed strategies should make the trial more appealing and result in a study population that is more diverse than that in our previous trials.